DMCC for ME/CFS: Recompete 2022 + CDE Admin Supplement

Project Summary
The Myalgic Encephalomyelitis/Chronic Fatigue Syndrome (ME/CFS) Collaborative Research Centers (CRCs)
Network was created to foster multidisciplinary research to inform the etiology, pathogenesis, and treatment of
ME/CFS, a debilitating, complex, multisystem disorder that affects approximately 0.9% of the population
worldwide. Although researchers have identified multiple hypotheses for disease etiology and differential
patterns in biological processes, the underlying mechanisms that trigger ME/CFS symptoms and their
treatment remain unknown. A comprehensive approach is needed to (1) identify subtypes of ME/CFS based on
biological markers and symptom classifications, (2) conduct longitudinal studies to understand the time course
of disease and its manifestations, (3) develop and validate outcome measures, including common data
elements, for future intervention trials, and (4) identify potential treatment targets. As the Data Management
and Coordinating Center (DMCC) RTI will (1) enable novel discovery through collaborative science by
expanding the content, userbase, and functionality of the mapMECFS data sharing portal; (2) advance
ME/CFS research through our secure online data portal with enhanced data collection, data sharing, and
clinical/biospecimen linkage tools; and (3) promote research efficiency and foster collaboration and
coordination by enhancing communication with ME/CFS internal and external partners, promoting the use of
common data elements, and providing logistical and administrative support.

Public health relevance
Project Narrative ME/CFS is a debilitating and complex disorder that affects millions of people worldwide; however, the underlying mechanisms that trigger ME/CFS symptoms and their treatment remain unknown. To better understand the causes and discover better diagnostics and treatments to improve the health outcomes for individuals with ME/CFS, RTI’s DMCC will continue to support this Network by (1) offering expertise in patient- centered research, data processing, and analysis; (2) providing tools to foster communication and monitor study progress; and (3) expanding the capabilities and reach of our publicly available ME/CFS research tools.